VERY LOW BIRTHWEIGHT INFANTS AND SURVIVORS OF ECMO TREATMENT

Modern methods of perinatal care have resulted in an increased survival of high risk infants. These infants have in the past contributed disproportionately to the neurologically impaired population. The purposes of this study are to (1) provide follow-up assessment of these infants,(2) provide for early intervention if required and (3) to assess the effects of new methods utilized in neonatal care settings. This study uses the developmental testing room in addition to the outpatient facilities. Approximately 150 new subjects are accrued each year and 350-400 continue in follow-up annually. Data back to 1983 includes >1800 infants.